DEVELOPMENTAL FUNDS

Developmental Funds are a significant source of essential resources for the Cancer Institute to take advantage of opportunities and plan new initiatives as determined by the Cancer Institute Executive Management Committee, and the Director of the Cancer Institute.